Identifying the Neurophysiological Phenotypes that Contribute to Alcohol-Related Blackout Susceptibility

PROJECT SUMMARY
Alcohol-related blackout has traditionally been considered a warning sign of the development of an
Alcohol Use Disorder (AUD). However, not all individuals who binge drink experience blackouts, and blackouts
are not uncommon among individuals considered social drinkers. While pharmacological and behavioral
factors contribute to blackout risk, they are not fully predictive. Recent work in the field has begun to consider
individual variability in blackout susceptibility, and the literature indicates that some individuals have a genetic
predisposition to experiencing blackouts. Preliminary work in our lab has indicated that having a history of
certain non-REM parasomnias classified as Disorders of Arousal (DoA) may increase one’s risk of
experiencing blackouts. Disorders of arousal, a diagnostic category that includes sleepwalking, are defined by
inappropriate motor arousal during slow-wave sleep. These arousal events are preceded by decreases in
functional connectivity between the motor cortex and prefrontal and subcortical targets, which allow for wake-
like activity in the motor cortex to occur simultaneously with slow-wave sleep elsewhere. Importantly, atypical
connectivity patterns persist into waking life in these individuals. As preliminary EEG work in our lab has
demonstrated abnormal patterns of resting-state EEG activity in individuals with a history of blackout, we
hypothesize that susceptibility to blackout and susceptibility to disordered arousal during sleep may be
mediated by similar baseline patterns of neural connectivity. Given the role of GABAergic interneurons in
modulating cortical functional connectivity, we hypothesize that individual variability in the efficiency of
GABAergic inhibition of the motor cortex directly contributes to blackout susceptibility. Preliminary work from
our lab has also indicated that self-reported feelings of stimulation in response to alcohol and self-reported
resilience to the motor effects of drinking (e.g., stumbling) are correlated with number of blackouts
experienced. We propose a model in which some individuals express a neurobiological phenotype defined by
reduced efficiency of GABAergic inhibition of the motor cortex, which results in unstable functional connectivity
at sober baseline and a relative resilience of the motor cortex to GABA-A mediated suppression of activity by
alcohol. When paired with steep elevations in blood alcohol concentration, we hypothesize that this phenotype
contributes to functional dissociation of the motor cortex and allows for motor activity past the point at which
long-term memory storage is impaired and behavior is disinhibited (i.e., the blackout state). The purpose of this
project is to investigate the role of GABAergic modulation of the motor cortex in blackout susceptibility using
non-invasive neurophysiological metrics to examine circuitry in individuals with a history of blackout and binge-
drinking controls. Identifying the neurobiological phenotypes associated with vulnerability to blackout could
pave the way for targeted interventions to reduce the significant physical and psychological risks associated
with alcohol-related blackout.

Public health relevance
PROJECT NARRATIVE Some individuals who binge drink are more likely than others to experience alcohol-related blackouts, and this individual blackout risk is not fully predicted by behavioral or pharmacological factors (e.g., body weight, rate of drinking, mode of consumption). People who report experiencing blackouts are at an increased risk of harms related to drinking, including physical injury and death. We hypothesize that there may be specific patterns of brain activity that make some individuals susceptible to alcohol-related blackout; identifying these biological risk factors would provide the foundation for targeted clinical interventions for those most at risk of serious injury resulting from alcohol use.